Interrupting the Intergenerational Transmission of Traumatic Stress: Identifying Parental Targets for Intervention by Looking Under the Skin

PROJECT SUMMARY/ABSTRACT
Parental psychopathology, including traumatic stress, presents significant risk to children’s
development and to their ability to benefit from evidence-based mental health services when needed. Child
interventions require parents to have specific and controlled responses to child distress and challenging
behaviors, yet these are the very moments that evoke negative emotions in parents. The emotional
dysregulation that underlies traumatic stress and related disorders may account for this hindrance in child
development and response-to-treatment, and thus, more refined work on parent emotion regulation (ER) is
sorely needed.
The proposed research and training will focus on enhancing the field’s knowledge of emotional
processes and response-to-intervention in parents who have experienced trauma. This is a particularly
important population in which to study parental ER, as the emotional symptoms of traumatic stress are diverse,
ranging from anger to horror to emotional numbing, and often arise unexpectedly. The proposed research will
use neurophysiological assessment (EEG) to elucidate emotional arousal, motivation, and regulatory
processes in N = 60 parents who experienced interpersonal trauma during their own childhoods, and who
currently have preschool-aged children (3- to 6-year-olds). The project design will include a clinical trial and
use of EEG biomarkers to measure response to a trauma-informed parenting intervention program.
In order to conduct the proposed research and to prepare the candidate for the next phase of her
career as an independent scientist, the proposed training provides guidance from an exceptional mentorship
team in the following goals: (1) enhance depth of knowledge and conceptualization of emotion, parenting, and
traumatic stress by applying biobehavioral and process-oriented, dyadic models to this work (2) expand depth
and breadth of knowledge and skills in psychophysiological methods, (3) develop the ability to conduct
independent research in the applied stages of translational science, (4) augment methodological and statistical
skills, and (5) increase opportunities for and skills in manuscript-writing and publication.
The proposed training will support the candidate’s long-term career goal to conduct translational work
that integrates novel, basic research on parental emotional processes with applied work on child and family
resilience, with the ultimate goal of preventing the intergenerational transmission of traumatic stress.

Public health relevance
PROJECT NARRATIVE Millions of U.S. parents have experienced trauma, putting them at risk for maladaptive parenting practices which then confer vulnerabilities to their children. The proposed research and training would lay a foundation for a career research program aimed at building resilience in traumatized parents and children by enhancing understanding of how parental emotional dysregulation associated with traumatic stress impedes effective parenting. The research proposes to use neurophysiological methods to address some of the challenges inherent in the study of emotion (particularly in trauma-exposed individuals) while utilizing clinical research methodology to identify biomarkers of intervention-response.